Modulatory Circuits in the Auditory System

Abstract
Acetylcholine is a neurotransmitter that plays a role in many aspects of hearing, including selective attention,
learning, frequency selectivity, sound localization, and discrimination of speech sounds. It also plays a critical
role in helping the brain adapt during normal development, during aging and in response to damage of the ear
or central nervous system. Top-down modulation, in which higher brain centers modify early acoustic
processing, contributes to many of these functions, often through interactions with cholinergic pathways. A
long-term goal of this research is to understand how cholinergic inputs modulate brainstem auditory processing
and how projections from auditory cortex contribute to these functions. The present proposal will address four
main gaps in our knowledge that limit our understanding of cholinergic function in the auditory brainstem. The
first gap in our knowledge is lack of information on sources of cholinergic input to most brainstem auditory
nuclei. Aim 1 will identify these sources by using recently developed viral vectors in newly created transgenic
mice. A second gap concerns divergent projections from individual cholinergic cells. Modulatory cells in other
brain areas typically have branching axons to allow widespread modulation. Aim 2 will use multi-label tracing in
transgenic mice to identify divergent circuits that could support concurrent modulation of large expanses of the
auditory brainstem. A third gap is a nearly total lack of information on cholinergic receptor types associated
with specific brainstem circuits. Numerous receptor types occur in the subcortical auditory system, suggesting
a variety of short- and long-term effects. Aim 3 will combine anatomical tract tracing with fluorescent in situ
hybridization (FISH) to identify specific cholinergic receptor components associated with particular ascending
and descending auditory circuits. The fourth gap in our knowledge concerns the identity of brainstem
cholinergic circuits that are directly contacted by projections from the auditory cortex. Aim 4 will use
conventional tracers as well as trans-synaptic intersectional viral methods in transgenic animals to test the
hypothesis that cortical projections contact cholinergic cells that innervate many subcortical auditory nuclei.
These results will identify the cholinergic circuits that are responsible for cortically-driven release of
acetylcholine. Overall, the results from the four Aims will provide fundamental information about brainstem
cholinergic circuits, their targets within the auditory pathway, and the extent to which they may be activated by
projections from higher brain centers. This information is essential for the design and interpretation of future
experiments to understand cholinergic and top-down modulation and for insight into therapeutic approaches to
prevent or treat deficits associated with dysfunction of these systems.

Public health relevance
NARRATIVE Acetylcholine is a neurotransmitter that plays critical roles in normal hearing and helps the brain adapt during development, learning and aging and after damage to the nervous system. Understanding these functions is critical for developing approaches to help people with age-related hearing loss, difficulty understanding speech in noisy environments, learning to hear with cochlear implants or coping with hearing dysfunctions in disorders such as autism or schizophrenia. The present proposal will answer critical questions about the circuitry that underlies cholinergic function in the brainstem.